Research Career Scientist

Current Research Activities
Ototoxicity is a common side effect of platinum-based chemotherapy that leads to significant negative health and
psychosocial consequences among adult cancer survivors (Miaskowski et al. 2018; Dillard et al. 2022).
Prospectively monitoring patients with cancer for early signs of ototoxicity provides the opportunity to mitigate its
adverse effects when the oncologist is able to modify drug treatment, and/or the audiologist can deliver timely
rehabilitation (ASHA 1994; AAA 2009). Unfortunately, significant barriers exist to integrating audiology supportive
services into oncologic care. Principal among these are barriers related to care and referral coordination with
oncology, audiology workload, and lack of protocols. Development of interventions is further hampered by
uncertain pathophysiology and variable patient susceptibility to ototoxicity, particularly as it relates to the
development of tinnitus and difficulties understanding speech in noise. The result is that ototoxicity management
(OtoM) as delivered currently in VA is elective care that occurs sporadically and fails to inform the patient’s
ototoxicity risk stratification, oncologic treatment or survivorship plan (Konrad-Martin et al. 2021, 2023).
The objectives of Dr. Konrad-Martin’s program of research are to: (i) construct tools to forecast individual patient
susceptibility to ototoxic hearing loss and tinnitus; (ii) test new hypotheses developed in animal models, about
the cochlear changes that trigger tinnitus and temporal processing problems in humans; and (iii) characterize
ototoxicity and OtoM from the perspectives of the patient and provider. For this research, patients receiving
cisplatin, carboplatin, or oxaliplatin are providing behavioral and physiological measures of auditory function
before, during, and after treatment. A subset contribute a blood sample for a genetic association pilot study.
i. Forecasting model development. We have developed a prognostic model to mathematically transform the
patient’s personal and treatment features into the expected post-treatment audiogram, which can be expressed
on a variety of measurement scales to address the clinical concern for patients, audiologists and oncologists
(McMillan et al. in progress). Into this model, we have incorporated population-based data from unexposed
controls on normal test-retest variability in pure tone thresholds. For Dr. Konrad-Martin’s SPiRE, model predictors
additionally include the presence and numbers of specific single nucleotide polymorphisms within four genes
selected for their potential association with cisplatin ototoxicity, including: ACYP2 (Xu et al., 2015); COMT
(Hagleitner et al., 2014); TPMT (Ross et al., 2009); and TRPV1 (Jiang et al., 2019).
ii. Relating ototoxic symptoms to the underlying auditory injury. A combination of wideband acoustic reflex (AR)
amplitude growth (Westman et al., 2021), and distortion product otoacoustic emission (DPOAE) levels is being
used to distinguish damage to the cochlear afferent system from outer hair cell dysfunctio n to determine the
extent to which tinnitus, speech understanding deficits, and reduced benefit from temporally-based spatial cues
can be attributed to cochlear injury, after controlling for cognitive function. Results are examined at one month
and one year after the initial chemotherapy treatment to allow for neuroplasticity within the central auditory
pathways (Kaltenbach et al. 1998, 2001; Chambers et al. 2016).
(iii) Characterize patient and provider perspectives on ototoxicity and OtoM. Patient and provider perspectives
on ototoxicity and OtoM are necessary to determine high value aspects of OtoM and barriers to care. Patient-
centered rating scales and questionnaires are being used to obtain the patient’s perspective on ototoxicity and
OtoM. We surveyed 63 VA audiologists and 12 VA oncologists nationally regarding their views on OtoM and
barriers to care. These results, together with completed work indicate that although OtoM has been
recommended for patients receiving cisplatin, carboplatin, or chemoradiation to mitigate ototoxicity, OtoM is at
best underutilized in VA (Konrad-Martin et al. 2021, 2023).

Public health relevance
Our recently completed clinical trial confirms that the rates of survival and of ototoxicity are high in VA cancer patients treated with cisplatin. We found that ototoxic hearing loss, when identified, is acted on by these patients and their oncology teams. Unfortunately, we currently cannot predict which patients will experience ototoxicity. Patients and their doctors also generally lack awareness of ototoxicity, which could prompt intervention to address its many negative health and psychosocial consequences. This research program is designed to fill these gaps in knowledge and clinical care to optimize post-treatment quality of life for the ~10,000 Veterans a year who receive ototoxic chemotherapies. We will test hypotheses developed in animal studies for how tinnitus and speech understanding problems develop in humans. We will refine our tools to forecast an individual patient’s risk for ototoxicity prior to treatment, including through genetic association studies. Additionally, we will partner with patients, oncology teams, and industry to improve access to and uptake of ototoxicity management.